Biofabricating Seminiferous Tubules for In Vitro Spermatogenesis

Project Summary
Failed spermatogenesis is a major cause of male infertility. In vivo, spermatogenesis occurs in seminiferous
tubules. The process is regulated by factors secreted by the interstitial tissue surrounding the tubules. An in
vitro testis cell culture system mimics the seminiferous tubule architecture and models spermatogenesis would
significantly advance fundamental studies and developing methods to prevent, diagnose, and treat infertility. In
past decades, scientists have developed various testis cell culture systems, including 2D culture and 3D cell
suspension culture with or without scaffold support for in vitro spermatogenesis (IVS). However, the cellular
organization of seminiferous tubules has not been successfully established in vitro. Because the architecture is
critical for spermatogenesis, the complete spermatogenesis cycle has not been efficiently achieved in vitro.
This project proposes using advanced micro-extrusion technology to precisely fabricate microtubes with
cellular composition and organization of the in vivo seminiferous tubules and surrounding interstitial tissue. For
convenience, it is termed bio-fabricated seminiferous tubules (BioSTs). The hypothesis is that IVS could be
efficiently achieved by establishing an in-vivo-like microenvironment. The proposed research is based on
advanced cell culture technologies from the PI lab and decades of studies on spermatogenesis from the Co-
PI’s lab. The PI has developed a new technology called AlgTubes for mammalian cell culture. AlgTubes culture
cells in micro-scale alginate hydrogel tubes suspended in a cell culture medium. The microtubes provide cells
with a physiology-relevant microenvironment, thus, significantly improving the culture efficiency such as
viability, growth rate, and yield. AlgTubes have many similarities to the seminiferous tubules, such as their
tubular shape, micro-scale diameter, and mass transport via diffusion through the tube wall. This project will
repurpose and further develop AlgTubes to build BioSTs with three specific aims: to fabricate BioSTs, to
characterize BioSTs including their architecture, blood-testis-barrier, spermatogonia stem cells maintenance,
male hormone production, and in vitro spermatogenesis for three months, and to validate BioSTs by modeling
findings from a previously studied mouse model with Premel1 knockout. BioSTs will be invaluable for
advancing the knowledge of spermatogenesis and male infertility. It also can be an alternative to animal testing
in high-throughput toxicity assays. This will reduce animal testing use and provide more accurate and relevant
results, as the in-vitro sperm will be derived from human cells. Moreover, prepubertal boys undergoing
gonadotoxic treatments are at risk for depleting their spermatogonial stem cells (SSCs). In-vitro-derived
spermatozoa can provide a solution for those boys. Similarly, the technology will benefit the infertility treatment
of non-obstructive azoospermia patients who cannot produce spermatozoa but still have SSCs.

Public health relevance
Project Narrative This project develops an in vitro testis cell culture system that can efficiently mimic the process of sperm production. The system can aid in advancing fundamental studies and developing treatments for male infertility.